Development and Commercialization of the Microphysiological Systems Database as a Sustainable Resource

Abstract
The Micorphysiology Systems Database Center (MPS-DbC) developed and implemented the
Microphysiology database (MPS-Db) enabling the management, analysis, sharing, integration of
diverse information and computational modeling of data in one platform, improving the
systematic way MPS users work. Aggregation of metadata, experimental data, and references
provides for robust and relevant interpretation of the results, and having the data centrally
located facilitates data sharing among user-defined collaborators and groups. Ready access to
experimental data, metadata, and reference data in a mineable format provides a convenient
platform for statistical analysis of MPS performance, and building computational modeling tools
to predict PK, identify compound mechanisms of actions, and infer pathways of disease
progression. We have been assisting users in capturing and managing MPS data, and the
MPS-Db is the central repository for the Tissue Chip Testing Center program data. We propose
to build the research and commercial value of the MPS-Db by: 1) continuing to support MPS
users to build database content; 2) enabling on-line preclinical/clinical concordance analysis
capabilities; 3) enhancing the suite of data mining and computational modeling tools; and 4)
augmenting methods for ensuring data quality and the secure, controlled release of data to
user-defined groups. We will implement a commercial version of the MPS-Db that can reside
on a controlled network behind corporate firewalls for the management of proprietary data while
still providing access to public MPS resources. Finally, we propose to establish a self-
sustaining MPS-Db and experimental analytics company that will generate revenue from
commercial users for the maintenance and further development of the MPS-Db for all users.

Public health relevance
Project Narrative The Microphysiology systems Database (MPS-Db) is an innovative advancement for the MPS community bringing together functions to manage, analyze, share, computationally model and integrate data in one platform. It is the first and only publicly accessible, comprehensive resource for sharing and disseminating MPS data and information currently supporting the non- profit MPS community. We will further develop data capturing and analytical features of the MPS-Db, build a commercial version for installation behind corporate firewalls, and establish a commercial entity to facilitate adoption of MPS technology with industrial partners and generate revenue to sustain the MPS-Db for all users.